Center for Identification and Study of Individuals with Atypical Diabetes Mellitus

PROJECT SUMMARY – OVERVIEW
ABSTRACT
Here we describe our vision for the National Center for the Identification and Study of Individuals with Atypical
Diabetes Mellitus in response to RFA-DK-17-006. The Center’s purpose is to convene key diabetes centers
with expertise in the clinical assessment, genetics, and physiological study of diabetes as institutional foci of a
nation-wide call for subjects with atypical forms of diabetes designed to:
a) Foster the study of individuals with rare/atypical forms of diabetes mellitus of unknown cause;
b) Identify and analyze phenotypic and genotypic defects that may provide insights into more common,
heterogeneous forms of type 2 diabetes mellitus (T2DM) in the general population; and
c) Develop a community resource to advance research in this area through a database to facilitate the
collection and dissemination of phenotypic and genetic data with biorepository samples and a living
biobank for access by the diabetes research community.
Our central hypothesis is that the identification and study of new cases of rare/atypical forms of
diabetes will yield greater insights into the etiology and genetic heterogeneity of T2DM.
The Center, building on the track records of the participating groups over the last three decades, will
support primary research endeavors to:
i. Build on our existing monogenic diabetes resources, genetics expertise, and deep knowledge of the
biology of diabetes to develop and implement processes (based on pedigree analysis and strategic
whole exome sequencing) for identifying and studying individuals/families with rare and
uncharacterized forms of diabetes;
ii. Create a national network of collaborators to help ascertain and initially phenotype the individuals in
pedigrees identified;
iii. Adapt our existing REDCap-based monogenic diabetes database to create and manage a study
database for rare/atypical forms of diabetes, a living biobank and biospecimen repository, and a public
portal for use by the diabetes research community in future studies; and
iv. Facilitate future investigation of the impact of genetic variation by providing access to biobanked
materials and the living biobank.
Detailed phenotyping, genotyping, and gene sequencing of these individuals and their families will help to
characterize rare atypical subtypes present in the spectrum of T2DM in the general population, and reveal
novel mechanistic pathways involved in the pathogenesis of diabetes. Knowledge of the pathways and their
constituent molecules should point to novel strategies for the treatment and/or prevention of T2DM.

Public health relevance
PROJECT NARRATIVE Diabetes affects almost 30 million Americans, and yet understanding of the molecular genetic basis of the phenotypic heterogeneity of the common forms of diabetes, especially T2DM, remains incomplete. We will pursue the identification and study of new cases of rare/atypical forms of diabetes that may yield greater insight into the heterogeneity of more common forms of T2DM. Detailed phenotyping and genetic analyses of these individuals and their families will help to characterize subtypes present in the clinical spectrum of T2DM in the general population and reveal novel mechanistic pathways involved in the prevention and/or treatment of T2DM.